Intestinal epithelial cell exfoliation by caspases

ABSTRACT
Many bacterial pathogens attempt to adhere to or invade intestinal epithelial cells (IECs), often using
virulence factors that manipulate cytosolic signaling pathways in the IEC. However, IECs are able to survey
their cytosol by using innate immune sensors in the inflammasome family. We have shown that
inflammasomes can detect the activity of bacterial secretion systems by detecting aberrant translocation of
bacterial flagellin, rod, and needle proteins.
Inflammasomes have largely been studied in macrophages, where active caspase-1 was first shown to
cleave pro-IL-1β and pro-IL-18 to their mature and released forms. Caspase-1 was recently shown to cleave a
third protein, gasdermin D, which forms a pore in the plasma membrane that causes programmed lytic cell
death, or pyroptosis. The function of caspase-1 in other cell types is now beginning to be studied, and these
may be slightly different from its function in macrophages. In this regard, in IECs inflammasomes were recently
shown to drive exfoliation of the compromised IEC, ejecting it into the gut lumen.
Caspase-1 is the founding member of the larger caspase family. Caspases are normally considered as
either apoptotic or inflammatory, however in recent years many interactions across classes have been
demonstrated. Here we examine how IECs are defended by caspase-1, but also that other normally apoptotic
caspases are also involved in exfoliation. We will study the innate immune inflammasome sensors that drive
exfoliation during bacterial infection, and also how different innate immune cells coordinate their activities to
promote IEC exfoliation.

Public health relevance
Project Narrative Bacteria are a frequent cause of gastrointestinal infection. The immune system fights back against bacterial infection in the gut by sensing the infecting pathogens when they perturb the intestinal epithelial cells that line the gut. This grant studies how intestinal epithelial cells detach as a defense against gut infection.